Development of AAV-AIBP for neuroprotection in glaucoma

PROJECT SUMMARY
Glaucoma is a leading cause of blindness worldwide. Emerging evidence suggests that glia-
neuroinflammation is a critical element driving retinal ganglion cell (RGC) death and optic nerve
degeneration in the pathogenesis of glaucoma. Gene polymorphisms in toll-like receptor-4 (TLR4,
inflammatory receptor) and ATP-binding cassette transporter A1 (ABCA1, cellular cholesterol
transporter) are linked to the risk of primary open-angle glaucoma. Our studies demonstrated increased
TLR4 and reduced ABCA1 expression in RGCs and glia in the human glaucomatous retina. We identified
the secreted apoA-I binding protein (AIBP) as a key regulator of cellular cholesterol metabolism, which
controls TLR4 activation via ABCA1-dependent cholesterol depletion from TLR4-occupied lipid rafts in
inflammatory and activated cells. Similar to ABCA1, AIBP expression was reduced, while cholesterol
levels and inflammatory markers increased in human and mouse glaucomatous retinas. Apoa1bp-/- mice
had compromised visual acuity and compared to the wild type, had increased retinal TLR4 and IL-1β
expression, augmented microglial activation, and increased RGC death in response to elevated
intraocular pressure (IOP). These findings support the rationale for the restoration of AIBP expression in
the retina to provide sustained neuroprotection in patients with glaucoma. In preliminary studies, adeno-
associated virus (AAV)-AIBP protected RGCs and ameliorated visual dysfunction in experimental mouse
models of glaucoma. In addition, recombinant AIBP protein promoted mitochondrial function as well as
inhibited inflammatory responses in cultured Müller glia and microglia in response to elevated hydrostatic
pressure. Based on our findings we proposed the development of AAV2-hAIBP-based therapy to reduce
retinal neuroinflammation and provide effective neuroprotection to glaucoma patients receiving standard-
of-care IOP-lowering treatment. This work is currently funded by the 1UG3NS129684-01A1 grant award.
The overall goal of the UG3/UH3 project is to conduct preclinical studies of an AAV-AIBP for the treatment
of glaucoma. The current lead construct encodes a secreted form of AIBP-His in which the C-terminal
6xHis augments the biological activity of AIBP. The goal of this supplemental proposal is to assess the
relative risk of immunogenicity between the two test samples, an AIBP-His recombinant protein, and
tagless AIBP, and in comparison, them with the clinically relevant controls with known immunogenicity.
These results will provide necessary data for an assessment of the risk of clinical immunogenicity for
AIBP-His and the selection of the final candidate for the development of the AAV-AIBP construct for
neuroprotection in glaucoma. It would also provide the flexibility needed to undertake the high-impact
1UG3NS129684-01A1 project and its on-schedule progression to the UH3 phase.

Public health relevance
PROJECT NARRATIVE Glaucoma is a leading cause of blindness worldwide. Despite the widely appreciated disease relevance of neuroinflammation and mitochondrial dysfunction as critical pathogenic elements, therapies targeting these processes are currently unavailable. The proposed immunogenicity assessment study supports the development of a novel AAV-AIBP gene therapy to reduce retinal neuroinflammation and provide effective neuroprotection to glaucoma patients.